AMD3100 TO MOBILIZE PERIPHERAL BLOOD STEM CELLS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Determine if AMD3100, given with a G-CSF mobilizing regimen is generally safe and well tolerated. Determine if AMD3100, given with a G-CSF mobilizing regimen will increase the number of peripheral stem cells collected for transplantation. This is a compassionate use program and although there are similarities, it's not considered a research study either by the FDA (Food and Drug Administration) or AnorMED, the manufacturer of AMD3100. Compassionate use is a way to provide experimental treatment to a patient who is not eligible to receive that therapy in a clinical trial, but who has a serious or life-threatening illness for which other treatments are not available. Information that is collected from this compassionate use program, however, will be used for research purposes.